Project 1

PROJECT SUMMARY
About 5% of non-small cell lung cancers (NSCLCs) are driven by chromosomal translocations of the anaplastic
lymphoma kinase (ALK) gene. ALK-positive NSCLC is highly sensitive to ALK tyrosine kinase inhibitors (TKIs),
and there are currently five FDA-approved ALK TKIs (crizotinib, alectinib, ceritinib, brigatinib, and lorlatinib) for
clinical use. While patients initially benefit from these ALK-targeting therapies, essentially all cancers will develop
drug resistance. Upon relapse, standard cytotoxic chemotherapy has modest activity and immune checkpoint
inhibitors (ICIs) do not provide any substantial benefit despite evidence that the expression of ALK by tumor cells
induces a spontaneous immune response in patients. In preclinical mouse models, we demonstrated that the
spontaneous ALK-specific immune response generated by ALK-driven lung cancers is insufficient to build an
efficacious anti-tumor response. However, a vaccine that potentiates ALK-specific immune responses in mouse
models can achieve a significant therapeutic effect including complete cure. Building on these studies, we
propose to develop the first therapeutic ALK vaccine for clinical use in patients with advanced ALK+ NSCLC. To
achieve this goal, through immunoproteomic analysis, we have identified the precise ALK peptides that are
processed by tumor cells and presented by two major MHC class I molecules in ALK-driven cell lines. We
confirmed that these peptides are immunogenic in transgenic mice, patients, and healthy donors. These
validated ALK peptides will be included in the formulation of an ALK vaccine for clinical use together with a novel
highly potent vaccine adjuvant. The clinical trial will also be supported with additional funding from industry and
foundation grants. Leveraging these data and support, we will launch a first-in-human Phase I clinical trial to test
the efficacy of the ALK vaccine in NSCLCs that have progressed after treatment with ALK TKIs. In this trial, the
safety, tolerability, and efficacy of the ALK vaccine will be tested in two cohorts of patients expressing either
HLA-A*0201 or HLA-B*0702 MHC-I molecules. The ALK vaccine will be added to ALK TKIs (cohort 1) or
administered together with an ICI (cohort 2) at the time of acquired TKI resistance. Circulating and intratumoral
immune responses to the ALK vaccine will be determined in treated patients. Potential mechanisms of escape
will be also studied in patients and mouse models. Finally, a discovery effort will allow the identification of ALK
peptides presented on additional MHC class I molecules to support a future design of a vaccine with broader
application to patients with different MHC-I molecules. Through this project we expect to develop the first cancer
vaccine to treat ALK-driven lung cancers that could be eventually use to treat any ALK-driven tumor.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer-related death in the U.S. and worldwide. About 5% of lung cancers are caused by a mutant gene called anaplastic lymphoma kinase (ALK). Although there are several FDA- approved ALK inhibitor pills available for treating this disease, essentially all ALK-mutant lung cancers will develop resistance to these drugs. We have developed a novel ALK cancer vaccine which extends lifespan in mouse models of ALK-mutant lung cancer. In this project, we propose testing this vaccine in patients with ALK- mutant lung cancer with the intent of stimulating patients’ immune systems to recognize and obliterate ALK- mutant cancer cells and cure patients of their cancer.